Precision Prostate Cancer Screening with Genetically Adjusted Prostate-Specific Antigen Levels

ABSTRACT
The United States Preventive Services Task Force (USPSTF) recently graded the use of prostate-specific
antigen (PSA) to screen for prostate cancer (PCa) a “C”: “For men aged 55 to 69 years, the decision to
undergo periodic PSA-based screening for prostate cancer should be an individual one and should include
discussion of the potential benefits and harms of screening with their clinician.” The USPSTF decided that PSA
screening as it currently exists is inadequate for widespread implementation. It is thus important to ask the
question how PSA screening can be improved to reduce overdiagnosis, overtreatment, and PCa mortality.
Evidence suggests that the incorporation of genetic factors into PSA screening decisions could do just that.
PSA levels have been shown to be highly heritable, but the associated genetic variants that have been
identified thus far explain only some of the variation. Moreover, the variation explained is even smaller when
dealing with non-European populations. If we can determine the genetic factors that predispose individuals to
high PSA levels independently of PCa, we could then account for them as part of a new PSA screening
paradigm. We propose to do just this with a large-scale project combining data from 17 studies of men both
with and without PCa, all of whom have data on both PSA levels and genome-wide variants. In sum, the
studies consist of 653,076 men, including 106,326 men of African ancestry, 35,683 of Latino ancestry, and
10,001 of Asian ancestry. In Aim 1, we will undertake a multi-ancestry genome-wide association study (GWAS)
of PSA levels that is 20-times larger than any previous such analysis, as well as the first ever transcriptome-
wide association study (TWAS) of PSA levels. We will then leverage the multi-ancestry nature of our sample to
discover additional genetic variants associated with PSA via fine mapping. In Aim 2 we will evaluate the
independence of the SNPs associated with PSA discovered in the GWAS and the genes associated with PSA
discovered in the TWAS using conditional analyses. We will then differentiate between genetic factors
associated with PSA and those associated with PCa using conditional and mediation analyses. Based on
these findings, we will create and test polygenic risk scores for PSA levels that combine associated genetic
factors together into single, powerful measures. Finally, in Aim 3, we will use measured PSA levels and genetic
factors—accounting for constitutive, non-PCa variability in PSA—to develop models that more accurately
predict PCa outcomes. These models will allow us to assess the benefit of additionally incorporating genetic
information with respect to deciding whether a man should undergo prostate biopsy. Our aims in aggregate are
promising toward reducing screening harms while improving screening benefits. In translation, clinicians and
patients could make more informed decisions, thereby reducing unnecessary procedures and diagnoses, and
preventing poor outcomes.

Public health relevance
PROJECT NARRATIVE The goal of the proposed research is to improve prostate-specific antigen (PSA) screening for prostate cancer (PCa) by removing inherent variability in PSA that is not due to PCa. PSA screening as it currently exists results in substantial overdiagnosis and overtreatment, but if we were able to use genetics to differentiate men with constitutively high PSA levels from those with high PSA levels as a result of undetected PCa, then we could reduce screening harms and boost screening benefits. We will leverage data from a large sample of individuals with both PSA and genetic data, to comprehensively determine genetic factors associated with PSA levels and develop and apply prediction models for PCa outcomes based on genetically adjusted life course PSA levels, PCa risk variants, and non-genetic PCa risk factors.